PCT-KUH: Pittsburgh center for training in kidney, urology and hematology

Abstract
The overall goal of the Networking Core is to build a vibrant and dynamic trainee community in kidney, benign
urology and benign hematology-based (KUH) research in Pittsburgh and Allegheny County. The Networking
Core activities are designed for trainees from high school students through to early career development
awardees who are engaged in basic bench science, translational research, data science, clinical research and
health services research. Engaging and exciting trainees early in their careers regarding KUH-focused research
areas is critical to address the declining numbers of individuals entering the biomedical research workforce. The
Pittsburgh region is uniquely equipped to leverage several already existing robust KUH-focused training
programs on which to build this community, that include high school summer student research experiences,
medical student/resident/fellow research and predoctoral/postdoctoral training.
The Networking Core will support a robust mentoring environment for all KUH trainees, in an effort to increase
the engagement of a diverse group of trainees early in their careers. The Core activities will include a weekly
KUH-focused research seminar series, face-to-face structured interactions across disciplines at our monthly
workshops, and active peer to peer, peer-near peer and alumni networks. The Core will leverage current seminar
series and other educational opportunities to promote inter-departmental cross-talk and team science. A new
virtual platform will be designed to sustain trainee interaction and provide an open forum to exchange ideas
using the Pitt Commons website as a backbone. The Networking Core will develop new community outreach
programs to local high schools and undergraduate schools, and leverage already existing recruitment efforts
from undergraduate summer student research experiences, the Physician Scientist Training Program (PSTP)
and the Medical Scientist Training Program (MSTP) to recruit from undergraduate colleges with significant
enrolment of students who are under-represented in science and medicine.

Public health relevance
The overall goal of the Networking Core is to build a vibrant and dynamic trainee community in kidney, urology and hematology-based research in Pittsburgh and Allegheny County. The Networking Core activities are designed for all trainees who are engaged in basic bench science, translational research, data science, clinical research and health services research.